Mothers and CareGivers Investing in Children: A virtual intervention to support healthy growth in infants and toddlers

Project Summary
Childhood obesity remains a significant public health problem and obesity risk begins early in life. There is a
need for accessible and comprehensive interventions focused on modifiable behaviors in infancy. This
proposal is an efficacy trial for the virtual Mothers and CareGivers Investing in Children (MAGIC) FEED+
program designed to foster responsive bottle and infant feeding and healthy eating habits starting in infancy,
compared to an attention control arm. Our pilot work has successfully implemented the MAGIC-FEED program
with responsive feeding coaching and focusing on complementary feeding to under and un-insured families in
the Austin area. The proposed research builds upon our partnerships and expands the intervention period to
earlier in infancy to include responsive bottle- and breast-ffeeding and includes longer-term follow up of infants
to disentangle the role of the intervention on child self-regulatory behaviors and longer-term adiposity. Our trial
will enroll 266 predominately low-income and Hispanic caregivers in early infancy and will deliver the
intervention starting at child age 3 weeks with intervention visits at 3 weeks, and 3, 6, 8, and 10 months. In-
person assessments of growth and body composition and child self-regulation will occur at child age 3 weeks,
and 13 and 24 months. Aim 1 focuses on main intervention effects on child growth and body composition. Aim
2 focuses on intervention effects on caregiver nutrition knowledge, and quality, caregiver responsive feeding
and child self-regulation, and examines the effect of MAGIC-FEED+ and the role of potential drivers of growth
(caregiver feeding practices and child self-regulatory skills) in infancy on children’s propensity to eat in the
absence of hunger and adiposity/body fat at 24 months. Aim 3 determines whether MAGIC-FEED+
demonstrates the factors necessary to be a successful intervention for broader dissemination. This proposal is
the first dynamic and interactive virtual trial designed to support heathy breast-, bottle and complementary
feeding with robust measurements of responsive feeding, self-regulation and adiposity. These results will
inform a pragmatic trial, and if effective, the MAGIC-FEED+ program is poised for wide dissemination and
public health impact.

Public health relevance
Project Narrative There is a need for accessible interventions to promote healthy growth and feeding practices in infancy to prevent later obesity. This proposal will evaluate an innovative virtual feeding intervention program for infants and their caregivers focused on optimizing infant breast-, bottle- and complementary feeding to support healthy growth and prevent obesity in the first two years. If effective, this program can be broadly disseminated to support healthy growth and obesity prevention.